Capitalizing on Artificial Intelligence to Capture Undiagnosed Structural Heart Disease from Electrocardiograms (CACTUS)

Structural heart disease (SHD), including valvular heart disease, right or left ventricular dysfunction, and various
cardiomyopathies, is a significant cause of cardiovascular morbidity and mortality. Despite the benefits of early
treatment, SHD remains underdiagnosed. Transthoracic echocardiography (TTE), a standard diagnostic
method, has limited use in population screening and in emergency departments (ED) due to cost and expertise
requirements. Patients from disadvantaged backgrounds, often relying on EDs for primary care, are particularly
affected. Traditional ECG interpretation fails in accurately detecting SHD, necessitating a novel approach. To
address this limitation, we created a deep learning model to interpret raw ECG waveforms, named EchoNext,
that generates a composite prediction for SHD with high accuracy to determine which ECGs should be followed
up by TTE. EchoNext is the first successful, unified model detecting all components of SHD from an ECG
waveform. The model was built using our database of 12 million ECGs and 1.5 million echocardiograms from 8
hospitals, 6 echocardiography labs, and 190 clinics serving a diverse population disproportionately at risk for
SHD. The EchoNext model has been retrospectively validated at 11 hospitals across 4 health systems that are
geographically distinct and serve diverse populations. This project will determine the accuracy of EchoNext in
the detection of undiagnosed SHD among patients presenting to six emergency departments. Our specific aims
are: 1) Perform a large, prospective, observational study to validate the accuracy of EchoNext in detecting
undiagnosed SHD, 2) Determine the impact of demographics/socioeconomic status on TTE referral rates and if
EchoNext accuracy varies in disadvantaged populations, and 3) Assess AI model performance stability over 4
years across various health system populations. This project aligns with NHLBI priorities by leveraging emerging
opportunities in data science to create a novel diagnostic strategy for SHD through the use of deep learning,
investigate factors contributing to health disparities, and study real-world performance to optimize future clinical
deployment of AI models. EchoNext may enable effective, equitable diagnosis of SHD to improve cardiovascular
outcomes for at-risk patients.

Public health relevance
Structural heart disease (SHD) causes significant cardiovascular issues but remains underdiagnosed, especially in disadvantaged populations who primarily use emergency departments (EDs) for care, due to the high cost and complexity of traditional diagnostic methods like transthoracic echocardiography (TTE). The EchoNext model, a novel AI-driven tool developed to interpret ECG waveforms, offers the first unified and accurate detection of SHD, aiming to help clinicians determine which patients need a TTE and improve timely diagnosis in at-risk patients. This project seeks to validate EchoNext's accuracy in detecting undiagnosed SHD in EDs, assess its performance across diverse racial, ethnic, and socioeconomic populations, and monitor its performance over time to ensure its clinical efficacy in improving cardiovascular outcomes.